University of Maryland Center of Excellence in Regulatory Science and Innovation

Project Summary:
We propose a 5-year renewal of the University of Maryland Center of Excellence in Regulatory Science and
Innovation (M-CERSI), a consortia of the two leading sister campuses within the University System of
Maryland, and the Food and Drug Administration (FDA). M-CERSI leverages the biomedical and health
outcomes strengths in Baltimore with the engineering and technologies strengths in College Park. Aims
include: Establish core program infrastructure and management plan to ensure success; Conduct regulatory
science research; and Provide regulatory science training/educational programs. Proposed research projects
align with FDA high priority topics, develop and evaluate methods to improve quality and safety, and/or
develop methods and tools to improve and streamline clinical and post-market evaluation. Research is
collaborative with FDA scientists and employs a vast array of research capabilities at UM. Research is
amplified by a robust training/educational program, which includes lectures, workshops, scholars program, and
the America's Got Regulatory Science Talent Competition. The sum of these activities describe a vibrant,
cutting edge Center that stimulates innovative thought, disseminates understanding of regulatory sciences and
practices, and generates new knowledge in support of the FDA's fundamental mission – to promote and
protect the public health.

Public health relevance
Narrative Statement We propose continuation of M-CERSI that fosters FDA-oriented research, as well as training/educational programs. The Center's mission is to foster the development of regulatory science – the science of developing new tools, standards and approaches to assess the safety, efficacy, quality and performance of FDA-regulated products. Activities leverage the close geographic proximity between University of Maryland and FDA's main campus.